Chromosome Packing Inhibitors for the Treatment of Eye Infections

Chromosome Packing Inhibitors for the Treatment of Eye Infections
ABSTRACT
Bacterial eye infections frequently arise as a complication of corrective surgery or contact lens use.
Therapeutic treatment of such infections is often complicated by intrinsic and acquired drug resistant
mechanisms, which eventually leads to irreversible eye damage and vision loss. Identification of antibacterial
compounds with a new mode of action could potentially alleviate this problem. This project seeks to evaluate
condensin inhibitors for efficacy during ocular infections. Condensins play a central role in global chromosome
organization and segregation and are required for virulence in diverse bacteria. In Pseudomonas aeruginosa,
condensins are integrated into the control of lifestyle and virulence and are required during eye infection. This
project will investigate how the inhibition of condensins affects the interaction of P. aeruginosa with the host
and examine the efficacy of the lead condensin inhibitor in an in vivo model of bacterial keratitis.

Public health relevance
NARRATIVE Bacterial eye infections, including endophthalmitis and keratitis, frequently accompany eye surgery and contact lens wear. A growing number of such incidents fail to respond to the available antibiotic treatments and often lead to vision loss. This project seeks to develop a novel family of antibacterial agents against eye pathogens.